Age, Gene/Environment Susceptibility-Reykjavid Study (AGES II)

Study was initiated to examine genetic susceptibility and gene/environment interaction as these contribute to phenotypes common in old age